Research Training in Complementary and Integrative Medicine

Project Summary/Abstract
This proposal is for a five-year continuation of the Harvard Medical School Research Fellowship
Program in Integrative Medicine (IM). This three-year program prepares both clinician and non-clinician
post-doctoral fellows for successful careers as academic research faculty and educators. The Harvard-wide
program is based within the Division of General Medicine at Beth Israel Deaconess Medical Center with
continued close collaboration with the Harvard Medical School (HMS) Osher Center for Integrative Medicine,
an inter-institutional program that facilitates the development of research and education across Harvard in the
growing field of complementary and integrative health (CIH) and whole person health. Our T32 training
program has continued to evolve with the field and align with NCCIH strategic plan and goals. We have
focused broadly on mind-body therapies (including mindfulness-based interventions, yoga, tai chi, and
‘placebo’ effects) that are long-standing areas of faculty expertise, as well as other areas within CIH such as
chiropractic and acupuncture. Areas of more recent interest and expansion include nutrition and supplements,
IM interface with technology, and a move towards implementation. Faculty mentors have funded research
programs in IM/CIH research and impressive track records of successful mentoring. All trainees take part in the
Program in Clinical Effectiveness, an intensive summer curriculum in epidemiology, biostatistics, and health
services research at the Harvard T.H. Chan School of Public Health (HSPH). Some trainees continue at HSPH
to earn a Master’s degree in Public Health during the first two years. Throughout the fellowship, weekly
programs including seminars in research methodology/skills (e.g. study design, statistical considerations, grant
writing) and a core program in evidence-based IM provides specialized clinical, research and scholarly skills in
CIH. Fellows can also take in-depth courses in CIH in order to acquire practitioner skills/certification to inform
their research. Most of the trainees’ time is devoted to mentored research, with careful matching of trainees
with appropriate mentoring teams with relevant and specific expertise. Each trainee uses skills learned in the
classroom to develop, conduct and analyze at least two original investigations under the direction of
experienced faculty mentors. Research may span clinical trials, epidemiology, health services research, basic
science and translational methodologies from bench to bedside. Fellows also participate in experiential retreats
and have opportunities to teach IM at HMS. Fellows may further cultivate clinical skills in IM at one of several
available integrative practice sites. Principal research mentors, clinical preceptors, and curriculum advisors
supervise each fellow’s development. Over the first 23 years of the fellowship, 36 fellows have completed the
program (38 in June 2023), 31 have earned an MPH, 22 have been awarded or have pending K career
development awards as a direct result of their T32 training. As one additional metric of success, many of our
graduates are now leading researchers in the field and direct prominent CIH programs nationwide.

Public health relevance
Project Narrative This post-doctoral research fellowship program trains individuals for careers in academic medicine to conduct scientific research in the field of complementary, integrative, and whole person health. This is an important and growing area of health that requires ongoing research to better understand mechanisms, efficacy, cost effectiveness, translation and implementation into our modern healthcare system.